Regulation of gene transcription and alternative splicing by a long non-coding RNA

Project Summary/Abstract
Research over the past decade has revealed the importance of long non-coding RNAs (lncRNAs) in the control
of cardiac remodeling and heart failure. We have characterized a cardiac specific lncRNA in the control of
calcium handling in human and mouse cardiomyocytes. Knockout of this lncRNA causes dysregulation of
calcium handling in cardiomyocytes and impairs cardiac function. Knockout mice are susceptible to cardiac
arrhythmias caused by catecholaminergic challenging and premature death. In this project, we propose to (1)
determine mechanisms by which lncRNA regulates gene expression at the transcription level, (2) determine
how lncRNA regulates gene expression at the alternative splicing level, and (3) determine cardiac protection
conferred by lncRNA in response to pathological stresses. The results from this project have the potential to
facilitate the development of novel therapeutics for heart disease.

Public health relevance
Narrative Dysregulation of calcium handling is common in cardiac arrhythmias and heart failure. There are millions of Americans living with heart failure and/or cardiac arrhythmias caused by electrical or mechanical abnormalities in the heart. Proposed studies in this project may lead to development novel therapeutics to treat patients with heart failure and/or cardiac arrhythmias.